Admin-Core

Abstract: Core A: Administrative Core
The Administrative Core A will provide the organization and oversight to facilitate overall program coordination
and maximize the impact of the combined program. Core A will 1) facilitate internal and external
communication and coordinate regular meetings among program investigators, staff, trainees,
scientific advisors and NIH, 2) Foster intra- and inter-NCTRI P50 collaborations, and 3) provide
regulatory and fiscal oversight to the program. Core A will schedule monthly meetings among all project
investigators and core directors to review progress, address challenges, troubleshoot, coordinate collaborative
experiments and plan future experiments. In conjunction with the monthly progress meetings, Core A will
schedule monthly journal club meetings that are open to all program investigators, staff and trainees. The
Scientific Advisory Committee(s) will join all program investigators for an annual program progress meeting
(1/2 day) to be held at the Tri-Institutional Symposium on Reproductive Biology and Infertility (Tri-Repro) that
rotates each year between MWRI/University of Pittsburgh, Cornell or the university of Pennsylvania in
conjunction with the NCTRI P50 Male Research Focus Group Meeting. Core A will also help coordinate the Tri-
Repro meeting each year in collaboration with P50 PDs and administrators at Cornell and the University of
Pennsylvania. The symposium will be organized by a committee of trainees for trainees. Core A will help
foster intra- and inter-P50 interactions by supporting collaborative pilot projects and by helping to disseminate
education/outreach teaching modules through project sites within this Reproductive Genetics and Therapy
NCTRI P50 center and to other P50 centers. The Core A Program Coordinator will assist the director by
helping with the submission of regulatory protocols and ensuring that all program sites and staff have the
appropriate training. Core A will also assist the Program Director with maintaining sub-contractual agreements
with all project sites, ordering, inventory, and monitoring the budget. Finally, Core A will work with all program
investigators to ensure that data are deposited in a timely fashion to a central repository that is accessible to all
project investigators. This will help to integrate data collected at different program sites; accelerate the pace of
research in individual projects and ensure that the program achieves an impact that is greater than the sum of
its parts. Cost effectiveness will be maximized by sharing data, knowledge and resources between projects. If
disputes arise, the Program Director (Dr. Orwig) will solicit input from the Scientific Advisory Committee.